Mentoring Institute for Neuroscience Diversity Scholars

R25NS076414 – Gonzalo Torres, PI
ABSTRACT
Despite many years of discussion, research, and efforts to promote change, a great disparity remains between
the presence of African American, Hispanic, Native American, People with Disabilities, and other
underrepresented minority (URM) faculty at US research universities and their representation in the US
population. This reality is no less true in the neurosciences than in other disciplines. Moreover, URMs who do
achieve faculty status appear to achieve traditional measures of success at a lower rate than do their majority
counterparts. Although data on publications and funding rates appear to be lacking, there is a striking absence
of URMs in visible positions of prominence as full professors or chairs at universities and as symposia speakers,
journal editors, or societal officers. We believe that these two problems are related - that if those URMs who are
faculty become more successful in regard to those measures, this in turn will stimulate an influx of other URMs
into faculty ranks. Our evaluation of available programs in the US indicates that there are limited opportunities
to adequately assist early career URM faculty in overcoming these difficulties, and it is this problem that we seek
to address through the Mentoring Institute for Neuroscience Diversity Scholars (MINDS) to promote the
advancement of junior faculty members in the neurosciences at research universities. Defining success for such
faculty in terms of quality and quantity of manuscripts, grants submitted, and funded, visibility at the national
level, mentoring of others by the participants, and promotion, we propose to establish a program based on the
following hypothesis: The success of early career URM faculty in neuroscience can be increased substantially
by an intensive individualized educational program focused on (1) and individualized career development plan
and the identification of a team of relevant mentors (2) strong instruction in professional skills and the responsible
conduct of research (RCR), (3) individualized and frequent mentoring by senior established faculty (4)
development of an expanded network and peer-mentoring, and (5) the promotion and enhancement of the career
of URM faculty at their own institutions. To test this hypothesis we will continue the MINDS program to advance
the development of URM faculty. We will recruit 10 early career URM faculty in neuroscience each year who
have great promise for success. We will then develop career development programs for each participant and
together the participant and mentoring team will develop a career development plan. To facilitate that plan we
will establish a two-year educational program consisting of (a) workshops, (b) strong mentoring, (c) attendance
at professional scientific meetings, (d) assistance in the expansion of their network, and (e) mechanisms to
promote communication and peer-mentoring among the participants. The impact of our efforts will be evaluated
and the results disseminated at meetings and in publications. We believe that this approach will have a significant
impact on the success of early career URM faculty in the neurosciences and will serve as a model for programs
in other areas of academia.

Public health relevance
R25NS076414 – Gonzalo Torres, PI PROJECT NARRATIVE The number of African Americans, Hispanic Americans, American Indians, and Pacific Islanders who are neuroscientists is much lower than would be expected based on their representation in the U.S. population. We will establish a national Mentoring Institute for Neuroscience Diversity Scholars (MINDS) program that will promote the advancement of these underrepresented minorities who are junior faculty members in neuroscience. The program will involve a series of workshops and mentoring over several years with instruction and mentoring in neuroscience research, professional development, and ethics provided by a large number of nationally recognized faculty members.